Bridging gaps in healthcare services for new familes due to COVID-19

PROJECT SUMMARY
The transition to new parenthood is marked by dramatic changes in social roles and responsibilities. To support
new parents, obstetric and pediatric healthcare surrounding this transition is designed with a supportive focus to
facilitate new parents' navigation of the attendant life changes. The COVID-19 pandemic has altered healthcare
delivery in ways that have limited these supportive obstetrics and pediatric services provided at the beginning of
new parenthood. Consequently, aspects of preventative healthcare, such as monitoring for symptoms of
postpartum depression, discussing optimal birth control options, educating parents on recommended adult and
pediatric vaccinations, and providing anticipatory guidance on infant wellness, are less robust. In addition,
without professional guidance and support, outcomes of foundational importance to new parents, such as
perceived stress, depressive and anxiety symptoms, or parenting and breast-feeding self-efficacy, are worse.
Moreover, the COVID-19 pandemic has underscored the impact of the social determinants of health on new
family wellness, with racial/ethnic minority and low-income families being differentially impacted by COVID-19
pandemic driven healthcare delivery changes.
Recognizing the potential for longitudinal changes in healthcare delivery engendered by the COVID-19
pandemic, a scalable, patient-centered, equity-focused intervention designed to bridge gaps in healthcare
services around the transition to new parenthood is needed. This
due
(N2H),
project, “Bridging gaps in healthcare delivery
to COVID-19 for parent and infants from birth through the first year of life” aims to evaluate Nursery2Home
a patient-informed digital healthcare intervention that
s
is specifically responsive to the COVID-19
pandemic's impact on new families, with a focus on health equity for racial/ethnic minority and low income
families. N2H builds upon previous digital health successes of our team while incorporating the evidence-based
collaborative care model for mental health support. N2H is designed to mitigate the adverse effects of healthcare
delivery changes in response to the COVID-19 pandemic and to improve health for mothers, fathers, and infants
over the first year of life. Developed from feedback given by new parents who delivered during the COVID-19
pandemic, N2H provides 1) parental education about their own physical and mental health, 2) infant wellness
resources and tracking of recommended healthcare services, 3) parental mental health screening and support,
and 4) systematic case review to optimize the health of new families.
We
assigned
improves
In
health
will test the efficacy of N2H via a randomized controlle trial. In total, 640 diverse families will be randomly
to either usual care or N2H intervention arm to evaluate whether, compared to usual care, N2H
healt services utilization and patient reported outcomes of foundational importanc to new families.
addition, we will evaluate the impact of N2H on racial/ethnic and income-based disparities observed in both
services utilization and patient reported outcomes.
d
h e

Public health relevance
PROJECT NARRATIVE The COVID-19 pandemic has transformed healthcare delivery; arguably, the fields of obstetrics and pediatrics have experienced some of the greatest changes as they have transitioned away from their role as a medical home and into more of an urgent care model of care. Nursery2Home is a digital health intervention designed to bridge the resultant gaps in obstetrics and pediatrics healthcare services for new families over the first year of life. This randomized controlled trial will evaluate whether, compared to usual care, Nursery2Home 1) improves maternal, paternal, and infant health service utilization outcomes over the first year postpartum, 2) improves maternal and paternal patient reported outcomes, and 3) reduces racial/ethnic and income-based disparities in preventive health services utilization and parental patient reported outcomes.